Mechanisms of Information Seeking in the Primate Brain

Project Summary. The brain systems that control our motivation, emotions, and decisions rely at their most
fundamental level on predicting the future: learning what outcomes to expect, when they will arrive, and how
valuable they will be. It is only natural that we are strongly motivated to seek information that will reduce our
uncertainty. But despite its importance in everyday decision making and clinical settings, little is known about
how information seeking behavior is controlled – how the brain anticipates information, endows it with value,
and sends it to motivational circuits to drive behavior.
We identified set of anatomically connected areas, including the anterior cingulate cortex and subregions of the
basal ganglia, that encode the quantitative level of reward uncertainty to control information seeking to resolve
that uncertainty. We also showed that the value of information is computed through a conserved algorithm in
the brains of macaques and humans, and that this algorithm governs value-based decisions through the lateral
habenula (LHb). Leveraging this insight, the Aims will answer several key questions. We will study a crucial but
understudied pathway in primates: concentrating on whether and how the thalamus causally mediates
prefrontal cortical computations that regulate information seeking. And we will assess how the anatomically
defined cortical-basal ganglia-thalamus loop performs the computational steps of estimating and representing
reward probability distributions, computing their uncertainties, and how it causally uses these representations
to set the value of information and regulate information seeking decisions.
Our key overarching hypothesis is that the thalamus transmits information about uncertainty to the cortex and
causally regulates cortical uncertainty processing to control information seeking. Aim 1 will uncover whether
and how the primate thalamus regulates the motivation to seek information to reduce uncertainty through
online modulation of the neocortex. Based on preliminary data, we hypothesize that anterior medial thalamus is
a key source of uncertainty signals, and that it causally regulates cortical computation to guide information
seeking. Aim 2 will assess whether and how different subregions within the cortical basal ganglia thalamic loop
represent probability distributions and their uncertainties and use them to motivate information seeking
decisions. Our hypothesis is that the decision variables in the cortex are computed from distributional
representations of value and uncertainty to guide deliberative information seeking decisions through LHb and
moment-to-moment information seeking behavior through the basal ganglia, and that these processes are
dependent on thalamic inputs. The Aims offer an unprecedented opportunity to understand the mechanisms of
information seeking, and to study clinically relevant primate brain areas that have remained understudied. In
the long term, research on information seeking will provide crucial insight about neural circuit function in health
and disease in an age in which information seeking has become a critical component of adaptive behavior.

Public health relevance
Project Narrative. The control of behavior, at its most fundamental level, relies on the motivation to seek information about the future, so that we can make good predictions and adaptively adjust our expectations. Malfunctions in these processes are associated with psychiatric disorders and maladaptive behavioral states, such as anxiety, persistent risk-seeking, obsessive compulsive disorder, and drug-addiction. This project aims to discover how the brain controls information seeking, how it anticipates when new information will arrive and what it will tell us, and how it uses this information to help us make adaptive decisions about the future.